Systems Biology Core

The overall goal of the Systems Biology Core (Core C) is to provide computational genomics and machine
learning (ML) modeling expertise to the 3 projects in the P50. This expertise will utilize high dimensional datasets
generated by the research projects including scRNA-seq, scATAC-seq and proteomics. These datasets will be
leveraged using a suite of computational tools, either individually or in an integrated manner to address major
biological questions posed by the research projects. Thus, the Core C team will function as an essential
collaborative group that will help to test hypotheses and to generate predictions as well as causal inferences
underlying the pathophysiology of distinct manifestations of SSc (Project 1) including SSc-ILD (Project 2) and
SSc-PAH (Project 3).
The aims of Core C include the inference of cell-intrinsic TF-directed genomic programs and cell-extrinsic,
intercellular signaling pathways underlying SSc cellular states as well as the identification of gene/protein and
module-centric predictive biomarkers of SSc outcomes. These will be enabled via a wide range of state-of-the-
art computational genomics and machine learning approaches. Overall, Core C is strongly integrated with the
key biological objectives of all 3 projects.